Lung Transplant Clinical Trial Network (LT-CTN)

ABSTRACT
This Lung Transplant Clinical Trials Network (LT-CTN) CTOT-CA consortium includes eight of the leading high-
volume, research-oriented adult and pediatric lung transplant programs in North America. Long-term survival
after lung transplantation is limited by chronic lung allograft dysfunction (CLAD), the final manifestation of chronic
lung transplant rejection. CLAD is not effectively prevented by lung transplant immunosuppression, as over 50%
of transplant patients develop CLAD within five years. Growing evidence suggests upregulation of inflammatory
cytokines in the lung allograft contributes to CLAD development through innate immunity and allorecognition-
driven adaptive immune responses. Our preliminary data demonstrate that post-transplant acute rejection (AR),
lymphocytic bronchiolitis (LB), organizing pneumonia (OP), or acute lung injury (ALI) increase CLAD risk and are
associated with elevations of Types I & II cytokines in the lung fluid. Because Type I/II cytokines share signaling
through the Janus Kinase (JAK) family, blocking the relevant JAKs could be an effective strategy to limit
inflammatory cytokine responses and prevent CLAD. Our data demonstrate that itacitinib, a selective JAK1 and
partial JAK2 inhibitor being tested in patients with bone marrow transplant, is effective in preventing AR in a fully
mismatched murine orthotopic lung transplant model, and that JAK1 is highly overexpressed in human lung
transplant CLAD. Thus, we hypothesize that addition of itacitinib to standard post-transplant immunosuppression
will reduce inflammation due to cytokine signaling, diminish further innate and adaptive immune responses, and
prevent CLAD. To test this, we propose to complete the INhIBIT-CLAD (ItacitiNIB randomized, multi-center,
double-blind, placebo-controlled trial to reduce lung Inflammation and prevenT CLAD) study, enrolling 450
bilateral lung transplant recipients over two years and randomizing 280 of those at higher CLAD risk (evidence
of AR, LB, OP, or ALI) to treatment with itacitinib or placebo and follow-up over three to five years, to detect the
primary outcome of CLAD. We also will collect biospecimens from all enrolled participants and conduct
mechanistic studies using lung fluid and tissue from randomized patients to determine how innate immunity and
adaptive immune responses that contribute to CLAD development are mitigated by selective JAK inhibition with
itacitinib. Finally, as Cytomegalovirus (CMV) is another key CLAD risk factor – and preventable – we propose a
multi-center infectious disease study targeting prevention of CMV infection after lung transplant using novel
measures of CMV-specific immunity to personalize antiviral prophylaxis duration. Our highly qualified team of
investigators bring longstanding, collaborative, highly relevant experience, including leading the adult CTOT-20
and-22 and the pediatric CTOTC-03, -05, -08, and -11 studies. Successfully completed, the studies now
proposed have potential to transform clinical practice, improve lung transplant outcomes, and expand treatment
paradigms for immune suppression and anti-viral prophylaxis after solid organ transplantation.

Public health relevance
PROJECT NARRATIVE Lung transplant extends the lives of patients with advanced lung disease, but long-term survival is limited by development of chronic lung allograft dysfunction (CLAD). To reduce CLAD and improve lung transplant outcomes, including both survival and quality of life, we propose a clinical trial testing a novel drug that prevents inflammatory cytokine signaling with complementary mechanistic studies to determine treatment effects on innate and adaptive immune responses.